Training Core

ABSTRACT – TRAINING CORE
Science and health related research is more promising today than ever before. One can scarcely keep up with
all the latest discoveries in genomics, transcriptomics, proteomics, and metabolomics. New medical
discoveries and health care reforms are emerging at a pace that far exceeds our current capacity to translate
new tests and treatments into an ever-evolving clinical environment. As such, while training in the skills
required for bench to bedside translation remains fundamental, there is also a compelling need to expand the
pool of scientists capable of performing cross-disciplinary areas such as the systems biology, epidemiology/
health services and implementation research necessary to translate scientific discoveries into day-to-day
clinical practice. The objectives of the University of Michigan Kidney, Urology and Hematology Research
Training Network (UM KUHR) TL1 are to provide early-stage, academically inclined scientists and
physicians with the requisite skills and experience across the translational research spectrum to
bridge the persistent gaps between basic scientific discovery, clinical practice, and population health.
The proposed training program consists of two principal components: 1) Didactic course work with
concentrations in basic science, bioinformatics, clinical trials, epidemiology, health services research or
implementation science; and 2) Concurrent applied in-depth research experience in the conception, execution,
and dissemination of a well-designed research project. In order to adapt to the needs of the healthcare
marketplace, the program will have broad criteria to matriculate both predoctoral and postdoctoral trainees who
are pursing or have either an MD and/or PhD. Guided by their program faculty preceptor, trainees will be
instructed in the philosophy, ethics, and theory behind research, as well as methodological techniques derived
from a broad array of basic, clinical, and public health sciences. The Programs Leads will undertake
administration of this program while progress will be monitored continuously by Program Faculty Preceptors,
and quarterly by the Selection and Mentoring Committee. Trainees will be expected to present their work to
the Selection and Mentoring Committee, at local and national scientific conferences and the UM KUHR Annual
Regional Research Retreat. By the end of the training program, trainees will have completed both the
requirements for an advanced research degree and a mentored research project, including publication of their
findings in the peer-reviewed literature. Based on our past records, graduates of our institution’s training
programs are well-positioned to establish a longitudinal research agenda and to pursue an independent
research career in academic medicine.